Pilot and Feasibility Program

SUMMARY
The mission of the Pilot and Feasibility (P&F) Program of the Penn DRC is to foster the development of new
investigators and to provide seed support for innovative high-risk diabetes related projects, with an increasing
emphasis on clinical and translational science. Over the past 2 funding periods (10 years), the Pilot and
Feasibility Program has been highly successful in this regard. 36 investigators received P&F awards and, of
these, 80% have garnered independent NIH support, the majority as R01s directly related to their P&F awards.
During the previous funding period 23 traditional P&F grants were awarded among 74 applications submitted by
investigators representing 11 Departments spanning multiple Schools and Institutes on the campus of the
University of Pennsylvania as well as other Philadelphia Institutions. Of the funded grants, 70% were to new
investigators and 22% were dedicated to clinical and translational projects. During the next funding period we
propose to continue this core mission of the Pilot and Feasibility Program while also increasing our efforts to
support underrepresented minority investigators and trainees engaged in diabetes research. Given the past
successes of the program, the increasing cost of performing research in the setting of an ever more competitive
funding environment, and the clear need based on the steady influx of applications, it is critical to continue the
mission of the P&F Program.